InHANCE: Imaging Innovation for Head And Neck Cancer Evaluation & Treatment Delivery

ABSTRACT: Overall
Head and neck cancer afflicts nearly 65,000 persons annually in the United States, with an explosive growth, in
what has now reached epidemic levels, human papilloma virus associated (HPV+) squamous carcinoma.
Advances in therapy and changes in etiology have resulted in long-term survival for the majority of head and
neck cancer patients; however, nearly all patients report therapy-related side effects from locoregional therapy
(i.e., surgery or radiotherapy) due to normal tissue injury, such as xerostomia, osteoradionecrosis and deglutitive
muscle damage, with a majority reporting one or more moderate-severe symptoms that impair quality of life. For
highly curable HPV+ cancers, competing risk of therapy associated aspiration morbidity may match or exceed
cancer-specific mortality, for example. Consequently, innovative strategies to identify, monitor, and prevent
therapy-related normal tissue injury are a significant unmet need in public health.
Because classic staging and therapy selection have focused necessarily on tumor characteristics, strategies for
normal tissue injury reduction via surgical or radiotherapy modification have largely not been patient specific.
Similarly, assessment and diagnosis of normal tissue damage has been symptomatic-driven and qualitative, as
a reactive post-therapy measure. Using advanced imaging and computational image analysis, how best to
execute image-guided interventions to reduce normal tissue injury and quantitative monitoring of spatial patient-
specific normal tissue injury, remains a knowledge gap to be answered in the current proposal.
Our central hypothesis is that through computationally assisted analysis of advanced imaging, we can better
predict, detect, prevent, and manage normal tissue injury, and simultaneously reduce normal tissue injury from
image-guided surgery/radiotherapy. This will be investigated by leveraging novel functional and anatomic
imaging of spatially distinct normal tissue injury, using state-of-the art computational approaches to improve
patient risk stratification and extending post-therapy mitigation of adverse late effects through image-guided
surgical and chemoprevention efforts.

Public health relevance
NARRATIVE: Overall The majority of the 65,000 head and neck cancer patients treated annually report one or more moderate- severe side-effects not from tumor, but from the consequences of curative therapy. This P01 application entitled “InHANCE: Imaging Innovation for Head and Neck Cancer Evaluation & Treatment Delivery” will have a positive impact on public healthcare by improving imaging detection, monitoring, and treatment of disease through a series of interlinked projects united under a thematic emphasis on rigorous quantitative approaches for toxicity reduction in head and neck cancers. We propose a Program to enhance these synergistic projects through core resources, towards the development of new biomedical imaging techniques, risk stratification, therapeutic approaches, and novel devices to fundamentally improve the detection, treatment, and prevention of therapy- and disease-related injury to normal tissue, improving outcomes by reducing sequelae while preserving or enhancing rates of cancer cure.